Targeting Undruggable Transcription Factor HoxB13 to Inhibit Prostate Cancer Metastasis

Project Summary/Abstract
Metastasis is the leading cause of cancer-related deaths. In patients with metastatic castration-resistant
prostate cancer (mCRPC), although bone is the most prevalent site of metastasis, the existence of metastases
in visceral organs such as the liver and lungs leads to the poorest prognosis. Current androgen receptor
signaling-targeted therapies have not vastly improved overall survival in mCRPC patients. There remains an
urgent need for the development of novel therapies for mCRPC patients, particularly those visceral and bone
mCRPC patients who have the worst prognosis or a high prevalence. We and others have found that mCRPC
cells highly express the oncogenic transcription factor (TF) HoxB13, which has been shown to promote CRPC
growth, invasion and metastasis, However, the precise molecular and genomic mechanisms that underlie the
oncogenic functions of HoxB13 remain largely unknown. Furthermore, like the majority of TFs, HoxB13 is
considered untargetable by traditional, small molecule-based drug design. Gene therapy is a critical alternative
strategy with the potential to directly target such traditionally undruggable genes. We have developed a lipid
nanoparticle (LNP) system for safely delivery of the highly specific RNA-targeting CRISPR/Cas13d (CasRx)
system to knock down mRNAs of transcription regulators in prostate cancer. By combing the LNP-CasRx
system with the visceral organ-targeting SORT (selective organ targeting) nanotechnology, or incorporating
the bone-targeting chemical alendronate into the LNP, and further modifying these visceral- or bone-targeting
LNP surfaces with the prostate cancer-specific aptamer E3, we have successfully developed and tested a tri-
targeting LNP system, simultaneously targeting 1) specific organs including liver, lungs or bone; 2) metastatic
cancerous cells (mCRPC cells); and 3) mRNAs encoding TFs (HoxB13). In this proposal, we hypothesize that
HoxB13-driven oncogenic transcription and CRPC metastasis can be counteracted by a CasRx-based LNP
system with specificity, efficacy, and safety. In Aim 1, we will uncover molecular and genomic mechanisms by
which HoxB13 activates oncogenic transcription in CRPC. In Aim 2, we will assess the therapeutic efficacy,
safety and molecular impact of the CasRx-based tri-targeting LNP system in CRPC. The data generated from
this proposal will provide key preclinical information about the efficacy and safety of this tri-targeting
therapeutic strategy, forming a basis for future medical application of a nanoparticle-delivered RNA targeting
system to inhibit HoxB13-driven oncogenic transcription in metastatic CRPC.

Public health relevance
Project Narrative The proposed studies will provide a preclinical basis for the development of a nanoparticle capable of delivering an effective and safe RNA-targeting gene therapy directly to castration-resistant prostate cancer (CRPC) visceral and bone metastases for HoxB13 targeting. The successful translation of this system to future medical applications could significantly enhance the well-being and reduce the mortality of men suffering from metastatic CRPC, a condition that currently lacks a standard effective therapy. Additionally, the RNA-targeting CRISPR/Cas13d system represents a highly flexible technology that could impact the larger field of translational science, allowing for the design of Cas13d-based nanoparticles targeting other previously- undruggable oncogenic transcription factors in prostate cancer and other solid tumors.